Development of a Novel Calcium Channel Therapeutic for Opioid Use Disorder

Vivreon Biosciences, LLC
4940 Carroll Canyon Rd., Ste. 110
San Diego, CA 92121
[email]
NIDA RFA-DA-23-021
Project Summary
Opioid use disorder (OUD) is the chronic use of opioids that causes clinically significant distress or impairment.
Most hospitalized patients admitted to the trauma unit or intensive care unit (ICU) receive opioids, commonly as
part of analgesia and sedation regimens. Repeated opioid exposure produces behavioral sensitization that
contributes to drug craving, opioid-induced hyperalgesia (OIH), and withdrawal symptoms. Opioid dependence
can be expected in hospitalized patients who have received lengthy opioid dose regimens, and patients are at
significant risk of continuing opioid use following discharge. Inpatient stays are often extended to taper dosages
and wean patients off opioids, yet these patients remain at increased risk of opioid dependence, withdrawal, and
OUD. This cycle of opioid treatment, opioid dependence, opioid tapering, and potential for developing OUD upon
discharge represents an urgent unmet medical need that contributes to the opioid pandemic. A small molecule
therapeutic that prevents opioid dependence would reduce the length of hospital stays, improve patient
outcomes, reduce the risk of OUD, and significantly reduce the cost of care. Vivreon Biosciences intends to
address this unmet need by developing a non-opioid new chemical entity (NCE) for prevention of opioid
dependence to combat OUD.
Tissue damaging microgliosis, the shift of quiescent CNS microglia towards inflammatory behaviors in response
to specific signals such as opioid receptor (OR) activation, is documented to be associated with OUD.
Therapeutic prevention of inflammatory microgliosis is an innovative approach to preventing the development of
opioid dependence. Central nervous system microglial cells are activated by ORs and support inflammatory
microglial polarization. We have demonstrated that our candidate therapeutic blunts multiple dimensions of
morphine-induced behavioral adaptations. In this Fast Track SBIR project Vivreon will build a full preclinical
development program around our Lead VV molecule to treat OUD. In Phase I we will develop dose-response
metrics in a mouse model of opioid dependence with multiple readouts and dose-range finding studies to
establish therapeutic window indices for two therapeutic compounds. This will allow selection of the most
promising Lead compound for further development. Successful Lead selection will justify entering full
development studies in Phase II. These studies will encompass standard small molecule Investigational New
Drug (IND) efforts including ADME/PK, toxicology and manufacturing studies to de-risk the Lead. Successful
conclusion of the project will yield an attractive package that is enticing to third party investors able to provide
the financial support required for advancement of the Lead into clinical validation.

Public health relevance
Vivreon Biosciences, LLC 4940 Carroll Canyon Rd., Ste. 110 San Diego, CA 92121 [email] NIDA RFA-DA-23-021 Project Narrative Opioid use disorder (OUD) is the chronic use of opioid medications that causes clinically significant distress or impairment. Opioid dependence and OUD can develop upon accepted opioid therapy administered while in the ICU and other hospital care settings where pain treatment and sedation are needed. No pharmaceutical exists to prevent development of opioid dependence. With support from this grant project, Vivreon Biosciences seeks to further validate and advance a promising small molecule drug candidate to bring the first drug to market that can prevent development of opioid dependence.